Application of a mobile health platform for assessing cognition and psychiatric symptoms in Veterans

Suicide is a lethal problem for Veterans. A major challenge in predicting and preventing suicide is that ideation
and suicide behaviors fluctuate over time, as do the cognitive, emotional, and physical states that precede them.
Recent advances in mobile health technology hold promise for intensively measuring risk factors for suicide that
are proximal, time-varying, and occur naturalistically in daily life using smartphones. Cognitive factors - including
cognitive control and social cognition - play a role in suicide risk; to date, however, mobile health tools have not
been adopted to objectively measure cognitive performance fluctuations in Veterans. To address this gap, we
propose to use our previously developed mobile health tool for measuring cognitive control and social cognition
in the daily lives of Veterans with elevated suicide risk. Drawing on our experience delivering mobile health
assessments in individuals at-risk for suicide, we will examine the dynamic relationships between cognitive
performance and suicide, as well as other contextual variables associated with suicide risk. A transdiagnostic
sample of Veterans with current suicidal ideation will complete concurrent mobile cognitive tests (MCTs) and
ecological momentary assessments (EMA) within a two-week intensive assessment. Our aims are to identify
associations between cognitive test performance and constructs closely linked to suicide risk (restricted coping
ability, negative interpersonal beliefs, ideation). We also seek to examine how relationships established in the
intensive mobile health longitudinal dataset relate to real-world suicide outcomes which we will derive from the
electronic medical record and telehealth assessments. We will use the dataset to identify subtypes of Veterans
based on their temporal pattern of suicidal ideation and examine associations between subtypes and real-world
suicide outcomes. Finally, we will explore the role of specific context variables (e.g., sleep) in suicide risk.
Deliverables from this project will include an intensive longitudinal dataset that overcomes limitations of
traditional static laboratory-based assessments. This dataset can be leveraged to assess additional real-time
proximal risk factors associated with suicide in longitudinal studies and interventional research on the cognitive
underpinnings of suicide.

Public health relevance
Technology holds the potential to aid in understanding the real-world phenomenology of risk for suicide, including identifying potential targets for early intervention. This project will employ smartphone-delivered tests of specific cognitive variables and examine real-time relationships between cognitive dysfunction, negative emotions and social contexts, and suicide risk in Veterans. This pilot project implements mobile health tools for understanding the cognitive mechanisms underlying suicidal ideation outside of the laboratory, setting the stage for future mechanistic and intervention research.